Hybrid Effectiveness-Implementation Trial of a Nurse-Led Firearm Safety Intervention in the Pediatric Inpatient Setting

Enter the text here that is the new abstract information for your application. This section must be no longer than 30 lines of text.
The proposed study aims to reduce firearm-related deaths in children by scaling out an evidence-based secure firearm storage intervention. The rate of firearm-related deaths increased by 41% from 2018-2021 across all intents, and firearms are now the leading cause of death for youth ages 1-19. Secure firearm storage is a health behavior that is critical for reducing unauthorized access to firearms and the risk of suicide, homicide, and unintentional injuries. S.A.F.E. Firearm is an evidence-based intervention that includes (1) brief, parent-directed discussion on secure firearm storage using a motivational interviewing and harm reduction approach and (2) free cable locks offers to all parents during well child visits in pediatric primary care. Importantly, S.A.F.E. Firearm has potential to save lives beyond primary care, and pediatric inpatient settings are an advantageous context for S.A.F.E. Firearm implementation. Across the U.S. there are over 250 children’s hospitals, approximately two million children are hospitalized yearly, and parental engagement is a core feature of care. Children’s Hospital of Philadelphia (CHOP) is a large, nonprofit pediatric health care system with two freestanding children’s hospitals in the greater Philadelphia region. Our team has pilot tested firearm safety initiatives in the emergency department, select primary care sites, and the pediatric intensive care unit. Through our formative work, we have identified bedside nurses as vital potential implementers. In Aim 1 of this proposal, we will adapt S.A.F.E. Firearm for the pediatric inpatient setting and nurse-led delivery using intervention mapping. Anticipated products are an adapted intervention and optimized bundle of implementation strategies. In Aim 2 we will conduct a parallel cluster randomized hybrid Type 2 effectiveness-implementation trial across two CHOP hospitals. Twelve inpatient nursing units will be randomized to receive adapted S.A.F.E. Firearm or usual care, defined as routine clinical care plus free cable locks available in the hospital safety center. We will test whether parents exposed to adapted S.A.F.E. Firearm report greater improvements in secure storage (primary outcome) compared to parents exposed to usual care over one year of active implementation. Secondary outcomes are additional firearm safety behaviors (e.g., firearm removal). We anticipate 14,400 eligible patient visits across the 12 units. Guided by the RE-AIM framework, we will examine the effect of the implementation strategy bundle on S.A.F.E. Firearm outcomes in Aim 3. Our primary implementation outcome is reach (i.e., electronic health record-documented program delivery). Secondary outcomes include fidelity, acceptability, and maintenance. We will explore implementation strategy mechanisms via qualitative interviews with nurses. Aligning with NINR priorities related to promoting population health, our findings will accelerate research translation and serve the broader goal of reducing firearm-related mortality and improving health for all children and their families.

Public health relevance
PROJECT NARRATIVE This proposed study has important potential to impact public health and reduce youth firearm-related deaths by scaling out an evidence-based secure firearm storage intervention to pediatric inpatient hospital settings. This cluster randomized clinical trial will test both the effectiveness of an adapted secure firearm storage intervention in improving parent-reported secure storage and secondary firearm safety behaviors, as well as examine the effect of an implementation strategy bundle on intervention reach, acceptability, fidelity, and maintenance. Nurses will lead implementation, highlighting an opportunity for widescale impact by harnessing the expertise of frontline nurses in the work of firearm injury prevention.